Label-free imaging of CAR T cell metabolism

PROJECT SUMMARY / ABSTRACT
The goal of this proposal is to develop non-invasive single-cell technologies to improve the potency of T cell
therapies against cancer. The first 6 chimeric antigen receptor (CAR) T cell therapies were recently approved
and >800 CAR and T cell therapies are in clinical trials. However, barriers remain in achieving durable remissions
(>1 year) for ~50% of patients who receive CAR T cell therapy. Due to the rapid development of these therapies
and a great need for process optimization, we focus on improving three translational roadblocks to effective CAR
T cell therapy: (1) screening patients whose T cells are unfit for CAR T cell manufacturing, (2) optimizing in vitro
CAR T cell production for higher potency, and (3) identifying metabolic features of potent CAR T cells in vivo.
CAR T cell therapy could be improved by enriching for naïve and stem cell memory (SCM) T cells in starting
materials and final products. Deficiencies in naïve and SCM T cells occurs in ~50% of untreated cancer patients,
and manufacturing autologous CAR T cell products from these sources has been unsuccessful. Even if SCM T
cells can be isolated, after CAR incorporation, the expansion process typically diminishes potency through T cell
exhaustion. After infusion, the presence of memory-like phenotypes in vivo correlate with better responses. To
date, there are no robust, non-destructive technologies to monitor CAR T cell manufacturing to optimize
production and assess potency in vivo at a single-cell level. These issues limit the impact of CAR T cell therapy.
Current approaches to measure T cell function are labor-intensive, destructive, or lack single-cell resolution,
which limits the frequency or specificity of these measurements. For CAR T cell therapy to realize its clinical
potential, new methods are needed to monitor T cells for optimal potency throughout manufacturing and post-
infusion. Changes in cell metabolism provide an attractive yet under-explored assay to track T cell potency.
Previous studies, including our own, show that T cells undergo drastic metabolic changes with activation, and
that naïve, exhausted, and memory-like T cells have distinct metabolic features. Our preliminary data shows that
non-invasive single-cell imaging of the fluorescence intensity and lifetime of NAD(P)H and FAD (optical
metabolic imaging, or OMI) can predict CAR T cell manufacturing conditions that produce a more vs. less
potent anti-tumor response in vivo. Given these metabolic features of CAR T cell potency, we propose to
determine whether label-free OMI of T cell autofluorescence and multivariate models can identify patient T cell
fitness, optimal in vitro expansion conditions, and in vivo cell biomarkers of potent and persistent CAR T cell
response. Overall, these technologies will streamline processes and interventions for consistently potent T cell
therapy and increase our knowledge of CAR T cell metabolism in vitro and in vivo.

Public health relevance
PROJECT NARRATIVE Chimeric antigen receptor (CAR) T cell therapies are FDA-approved adoptive T cell therapies that have been genetically engineered to recognize and kill cancer cells and have improved complete remission rates compared to existing treatments with potential of long term cure. However, effective CAR T cell therapy is highly variable across patients. The label-free single-cell metabolic imaging technologies developed in this proposal could streamline processes and interventions for consistently potent T cell therapy and increase our knowledge of CAR T cell metabolism in vitro and in vivo.